Potentiating the Efficacy of Immune Checkpoint Blockade by Targeting Epithelial-Mesenchymal Transition (EMT)-induced Immunosuppression in Breast Carcinomas

Project Summary/Abstract
The Epithelial-to-Mesenchymal Transition (EMT) is a cell-biological process that drives the metastatic
dissemination of tumor cells and results in invasiveness, acquisition of tumor-initiating properties and
elevated resistance to treatment regimes. Using novel in vivo models of epithelial and mesenchymal
breast carcinomas, I have demonstrated that epithelial tumors are heavily infiltrated with biologically
active CD8+ cytotoxic T-cells, and contain low levels of immunosuppressive Tregs. In contrast, the
more mesenchymal tumors exclude exhausted, CD8+ cytotoxic T-cells and recruit immunosuppressive
Tregs and pro-tumor, M2-like macrophages instead. Most importantly, epithelial tumors are largely
sensitive to anti-CTLA4 immunotherapy, whereas the mesenchymal tumors are resistant. These
findings suggest that mesenchymal breast carcinomas assemble an immunosuppressive tumor
microenvironment (TME) and mount refractory responses to immune checkpoint blockade (ICB).
However, the precise mechanism(s) by which this occurs is unclear. Whether mesenchymal carcinoma
cells express cell-intrinsic immunosuppressive factors that directly regulate the refractory responses of
mesenchymal tumors to ICB is not known. For this reason, one goal of this proposal is to determine the
identity and function of mesenchymal carcinoma cell-intrinsic factors in regulating immunosuppression
and refractory responses to ICB. While my data demonstrate that only the tumors arising from
mesenchymal, but not epithelial cell lines are enriched in immunosuppressive cells, the functional
significance of these distinct subsets is unknown. Thus, another goal of this proposal is to determine
whether immune infiltrates themselves are involved in the induction and/or maintenance of an
immunosuppressive TME in the mesenchymal tumors. In addition to the aforementioned results, I made
the striking observation that a small minority (~10%) of more mesenchymal cells could largely protect a
majority (90%) of commingled epithelial carcinoma cells from elimination by anti-CTLA4. Thus, not only
are mesenchymal carcinoma cells immunosuppressive, but they also protect their epithelial neighbors
from immune attack. However, whether they do so by exerting immunosuppressive forces in a systemic
(endocrine) fashion or localized (paracrine) fashion is unclear. Hence the final goal of this proposal is to
explore how mesenchymal carcinoma cells protect epithelial cells residing within the same tumor from
immune attack. The work proposed in this proposal is likely to uncover the molecular players and
cellular subsets involved in inducing EMT-mediated immunosuppression. This study is expected to
have an important positive impact through identifying novel diagnostic and prognostic markers of breast
carcinomas that could potentially be used for immunotherapeutic intervention as well.

Public health relevance
Project Narrative Majority of deaths in breast cancer patients are attributed to the metastatic spread of the disease to distant sites potentiated by an immunosuppressive tumor-microenvironment and their resistance to various therapeutic strategies, including immune checkpoint blockade (ICB). This study aims to understand the mechanism(s) by which mesenchymal carcinoma cells resist elimination by ICB with the goal of identifying and interrupting signalling channels specifically associated with mesenchymal carcinomas to potentiate the effects of ICB. Thus, the proposed work highlights the prospect of using the polarization of carcinoma cells towards the epithelial-mesenchymal spectrum as a surrogate marker for predicting responses to ICB.